Administrative core

Summary
The Administrative Group will provide administrative structure and financial management support for the
research Cores so that they can serve the academic community and facilitate vision and ophthalmic research at
UCI. The Administrative Group will provide strategic planning, resource development and oversight, policy
development and implementation, joint resource management, information services, and distribution of funds.

Public health relevance
Project Narrative Not require per FOA.